Sensory Ion Channel Modulation by Bioactive Lipids

Our current research focuses on investigating the mechanisms by which bioactive lipids modulate the function
of vascular and sensory transient receptor potential (TRP) ion channels. Members of the TRP ion channel
subfamily are involved in various physiological processes, including temperature, chemical, and noxious stimuli
detection, as well as osmoregulation and neuronal and vascular function. TRP channel dysfunction underlies
different pathophysiological conditions such as pain hypersensitivity, peripheral neuropathies (e.g., during
diabetes), inflammation, hypertension, neurological disorders (e.g., cerebellar ataxia), and kidney disease. Since
TRP channels play critical roles in health and disease, there are many challenges that agonists and antagonists
must overcome during clinical trials due to their side effects. We envision that new strategies that fine-tune TRP
channels function, while maintaining their physiological roles, might circumvent undesired side effects of
pharmaceutical drugs. In the past five years, we have gained insights into the mechanisms by which
polyunsaturated fatty acids (PUFAs), phosphoinositide lipids, and diacylglycerol regulate the function of TRPV4,
TRPV1, and TRPC6, respectively. Combining various in vitro and in vivo approaches, we aim to depict the
mechanism by which ω-3 PUFAs increase TRPV4 function and its potential for ameliorating channel-mediated
vascular dysfunction. Moreover, we will focus on determining the structural bases of the TRPV1 C-terminal
domain interaction with the plasma membrane and the intrinsic sensitivity of TRPC channels to bioactive lipids.
Taken together, our proposed work is expected to provide the molecular framework for understanding how
bioactive lipids fine-tune TRP channel function in the vascular and nervous systems. These findings will, in turn,
facilitate the development of strategies to target TRP channels, without disrupting normal physiology.

Public health relevance
Members of the transient receptor potential ion channel (TRP) family act as biological sensors by decoding various physiological cues in the environment to regulate vascular and neuronal function. The proposed study is relevant to NIH’s mission because it will provide the molecular basis by which bioactive lipids modulate the function of vascular and neuronal TRP ion channels. The proposed research is relevant to public health because dietary consumption of polyunsaturated fatty acids, among other bioactive lipids, is known to prevent cardiovascular diseases and ameliorate neurological disorders.